Multi-modality Test for improving precision of TBI diagnosis in the elderly.

Project Summary/Abstract
Incidence, hospitalization, and mortality for traumatic brain injuries (TBIs) have greatly increased
in the past decade, even more so for the expanding geriatric population. Despite this, current
diagnostic and prognostic tools for TBI remain wholly inadequate. With this application, we
propose to test and optimize the performance of the BRAINBox TBI Test system, which has
received Breakthrough Designation from the FDA as a first in kind device providing both diagnosis
and prognosis of future symptoms. This test system can rapidly detect multiple highly specific
blood biomarkers and test neurocognitive performance in less than 20 minutes. Combining
functional and biological evidence of injury, this multimodality test provides the necessary data
for an instant readout of brain health. We will train the algorithms that provide the test result to
recognize patterns in individual patients that are specific for TBI even in the presence of cognitive
decline or dementia. This distinction is critical to effective diagnosis in this patient age group,
where brain injuries due to falls or other causes are too often left undiagnosed. This work will
adapt a novel, effective testing system to the needs of our growing geriatric population, which will
enable rapid mTBI diagnosis and prognosis at the bedside with a single device. Development and
validation of this product to address the underdiagnosis of geriatric TBI and help prevent the
frequent debilitating outcomes that are clinically elusive due to neurocognitive decline and
dementia.

Public health relevance
Narrative TBI is the leading cause of injury mortality worldwide, increases a person’s risk for subsequent TBI, and elderly patients are more prone to TBIs given increased prominence of polypharmacy, neurologic decline, functional deficits, and other chronic debilitations both pre- and post-TBI. The current diagnostic gold standard for TBI involves neurologic assessment and neuroimaging, both of which are increasingly unreliable in geriatric patients. Due these challenges, we propose to adapt a novel, multimodality testing approach to the specific needs of the elderly with head injuries and pre-existing cognitive decline, using a device that combines multiplex point of care assessment of blood biomarkers with concurrent functional neurocognitive assessment for diagnosis and prognosis.